Aberrant nuclear signaling in the islet beta cell under metabolic stress

PROJECT SUMMARY
Chronic exposure of the pancreatic islet β-cells to gluco- and glucolipotoxic conditions (metabolic stress)
induces dysfunction and loss of functional β-cell mass. However, putative molecular and cellular mechanisms
involved in the genesis of islet β-cell defects under the duress of metabolic stress remain partially understood.
Original studies from our laboratory in rodent and human islets have demonstrated novel roles for Rac1-
induced intracellular oxidative stress in β-cell demise under the duress of diabetogenic stimuli. Interestingly,
however, potential impact of metabolic stress on nucleocytoplasmic shuttling of key cargo necessary for
optimal β-cell function has never been examined. Based on compelling preliminary evidence, we propose to
evaluate the hypothesis that metabolic stress induces abnormalities in the karyopherin-α2 (KPNA2)-Ran
G protein modules within the nucleocytoplasmic shuttling apparatus culminating in aberrant import/export of
signaling proteins resulting in β-cell failure. We aim to assess our hypothesis via studies described under four
complementary Specific Aims in INS-1 832/13 β-cells, rodent islets, and human islets. Aim 1 will aim to
understand the impact of metabolic stress on KPNA2-Ran signaling modules leading to dysregulation of the
islet β-cell. Studies under Aim 2 will establish essential roles for the NADPH oxidase signaling modules (Rac1-
p22phox) in the onset of nuclear oxidative stress leading to β-cell dysfunction under metabolic stress.
Experiments under Aim 3 will delineate the proteomic signatures of Rac1-KPNA2 and their corresponding
signaling pathways in the nuclear and non-nuclear compartments derived from β cells exposed to metabolic
stress. Lastly, studies under Aim 4 will evaluate the therapeutic potential of targeting Rac1 (using novel small
molecule inhibitors) in alleviating intracellular oxidative stress and β-cell dysfunction in the diet-induced obesity
animal model. A variety of pharmacological, molecular biological (in/active mutants, siRNA/CRISPR/cas9 gene
editing), microscopic (BiFc) and proteomics (co-IP and UPLC-ESI-MS/MS) and bioinformatic approaches will
be employed to validate our hypothesis in rodent and human islets. To further enhance the translational
significance of our project, we will validate our working model in islets derived from T2DM donors. Our studies
are innovative and carry translational impact as they are expected to advance our current understanding of
the cellular mechanisms that regulate islet β-cell dysfunction in human diabetes. Most notably, nuclear
import/export of G proteins (Rac1, Ran) in islet β-cell in health and diabetes is an understudied area, and data
accrued in the proposed multidisciplinary investigations are expected fill these important knowledge gaps in
this field of islet biology. The data accrued from these investigations are also expected to provide actionable
insights that will impact the prevention and treatment of T2DM in humans including our aging Veterans.

Public health relevance
PROJECT NARRATIVE Emerging evidence suggests that long-term exposure of the islet β-cell to metabolic stress (e.g., high glucose and lipids) results in severe functional and metabolic defects culminating in cellular dysfunction and the onset of diabetes. Based on exciting data accrued from our original and ongoing investigations, we propose to investigate precise signaling mechanisms that underlie metabolic stress-induced oxidative stress, nuclear abnormalities, and β-cell dysregulation. Following successful completion of these studies, we will be able to identify novel therapeutic targets (e.g., Rac1) to prevent the establishment of these β-cell defects and loss of β-cell mass under the duress of metabolic stress leading to the onset of diabetes.